Identifying Leverage Points to Improve Care of Persons with Alcohol Use Disorder

Abstract
The long-term goal of this project is to conduct scientifically rigorous research that identifies critical leverage
points to improve alcohol use disorder (AUD) treatment during hospitalization while simultaneously acquiring
training that facilitates my career development and transition to an independent researcher. Receipt of this
NIAAA K08 Award will allow me to develop the skills and experiences I require in conducting advanced
quantitative analytic techniques, implementation science methodology, and scholarly and professional pursuits.
Through a combination of didactic coursework and workshops, attendance at national meetings, and mentoring
activities, I will acquire the expertise necessary to ensure I am well poised at the conclusion of the K08 Award
to execute a research agenda as an independent investigator at the intersection of AUD and implementation
science.
Using a mixed-methods approach informed by an implementation science framework, the research strategy
proposes to combine results from “big data”-- including insurance claims and electronic health record data--
with qualitative data from key stakeholders to identify leverage points within the hospital system to increase the
implementation of AUD treatment. The proposed project has the following specific aims: 1) examine the real-
world effectiveness of AUD treatment as measured by alcohol-related acute health care utilization; 2) examine
the prevalence and correlates of AUD treatment during hospitalization; and 3) use quantitative and qualitative
data inputs to model pathways for improved implementation of AUD treatment during hospitalization.
Completion of these Aims, which complement my training and career development goals, will provide important
information on how to improve the care of the high-risk population of hospitalized patients with AUD.

Public health relevance
Project Narrative Alcohol use disorder is a leading cause of preventable death in the United States yet fewer than 10 percent of persons with alcohol use disorder receive treatment, highlighting a significant implementation gap in this high- risk population. The proposed application aims to decrease this gap by improving our understanding of the real-world effectiveness of alcohol use disorder treatment, identifying barriers to alcohol use disorder treatment during hospitalization, and utilizing quantitative and qualitative data to model pathways to increase the implementation of effective alcohol use disorder treatment among hospitalized patients. Results from this proposal will lead to improved treatment implementation for persons with alcohol use disorder.